Development of Broadly Neutralizing Nanobodies for Advancing AIDS Therapy

Abstract
Human Immunodeficiency Virus (HIV) remains a persistent global health crisis, affecting approximately
39 million individuals worldwide, despite considerable advancements in prevention and treatment. While
strides have been made with antiretroviral therapies (ART) and other interventions, managing HIV
continues to pose significant challenges. Broadly neutralizing antibodies (bnAbs) have emerged as
promising tools against HIV-1. However, their widespread use faces hurdles such as resistance
development and complex administration. Consequently, exploring alternative strategies, notably
nanobodies, gains prominence in HIV research. Nanobodies, recognized for their compact structure,
effective tissue penetration, and unique epitope recognition, offer a novel avenue for combatting HIV.
This study concentrates on harnessing diverse nanobody development strategies to identify and engineer
these smaller antibodies, with a specific focus on targeting multiple sites on the HIV virus Env protein.
The primary goal is to bolster treatment effectiveness while simplifying therapeutic protocols. Empirical
evidence suggests that engineered antibodies, simultaneously targeting diverse sites on the HIV Env,
may outperform traditional bnAbs in efficacy against a range of HIV strains. Our proposal outlines three
primary objectives: first, identifying versatile nanobodies capable of recognizing various regions of the
HIV Env through advanced phage-display screening; second, conducting comprehensive
characterization, including neutralization studies, bioinformatic, and structural analyses, to deepen our
understanding of these nanobodies' mechanisms; and finally, enhancing their efficacy by leveraging
structural insights for rational design to broaden their targeting capabilities.
This thorough exploration into nanobody-based therapies holds significant potential to revolutionize HIV
treatment strategies. By potentially overcoming existing limitations and offering innovative pathways in
HIV management, these advancements could substantially impact the ongoing battle against this
persistent viral challenge.

Public health relevance
Public Health Relevance Statement Narrative HIV is a constantly changing virus, and current treatments face limitations. Our research on nanobodies aims to discover simpler and more effective ways to combat HIV, potentially revolutionizing treatment approaches for better health outcomes.